Facility/Service Core

Project Summary
The Facilities Core of the Lake Erie Center for Fresh Waters and Human Health will provide toxin and nutrient
analytical services for the integrated research projects. These labs are located at SUNY Environmental
Sciences and Forestry (toxins) and Ohio State University Stone Lab (nutrients). Routine weekly sampling
during summertime bloom season will yield 200 water samples (10 sites x 20 weeks) to be analyzed for soluble
and particulate nutrients as well as a full suite of toxins. Toxin analyses include both microcystins, the current
health threat in Lake Erie, along with toxins that may emerge regionally due to climate change
(cylindrospermopsin, anatoxin and BMAA). Funds are also available to process targeted samples obtained
through the citizen science Charter Boat Captain and US Coast Guard programs (see Community Engagement
Core). Additional sampling trips outside of the weekly routine sampling plan are provided through vessels
made available through the University of Toledo Lake Erie Center. All nutrient and toxin data will be publicly
available immediately following curation by the Data Manager at BGSU (see Administrative Core).